Characterizing the contribution of transcription-associated DNA-topoisomerase adducts to mutagenesis in cancer

Abstract
Mutations are the underlying cause of cancer and contribute to metastasis and resistance to cancer
therapeutics. In human cells, both perturbing transcription and inducing DNA-topoisomerase adducts are
known to cause DNA damage. However, the mechanisms generating transcription- and DNA-topoisomerase
adduct-associated mutations in human cells, the types of mutations caused by these processes, and their
contribution to mutations in cancer are poorly understood. Using a novel mutation reporter in human cells, we
observed a mutation spectrum dominated by 2- to 5-base pair (bp) deletions and distinct larger deletions. This
mutation spectrum mirrors that of DNA topoisomerase 1-dependent, transcription-associated mutagenesis in
S. cerevisiae, which indicates transcription-induced DNA-topoisomerase adducts produce these mutations in
human cells. We additionally found that 2- to 5-bp deletions are enriched within highly expressed genes in
primary breast cancers, suggesting DNA-topoisomerase adducts are important contributors to cancer etiology
as deletions of ≥ 2 bp constitute between 3% and 12% of all inactivating mutations in tumor suppressor genes.
The goal of this proposal is to characterize the basic determinants of transcription-associated, DNA-
topoisomerase adduct-induced mutagenesis in human cells and assess its contribution to mutagenesis in
cancer. Aim1 will determine the mechanistic basis of transcription-associated, DNA-topoisomerase adduct-
induced mutagenesis in human cells and define the spectrum of mutations generated by this process. This will
be accomplished by measuring mutation rates and spectra utilizing mutation reporters for which we will
modulate transcription via CRISPRi and CRISPRa and/or increase DNA-topoisomerase adducts by utilizing
topoisomerase variants and inhibitors. Also, we will determine the contribution of various end joining DNA
double strand break repair pathways and R-loop resolution to promoting or limiting specific types of DNA-
topoisomerase adduct-induced mutations. Aim 2 will determine the genome-wide distribution of both DNA-
TOP1 adducts at single nucleotide resolution using a novel genomics approach and DNA-TOP1 adduct-
dependent mutations via whole genome sequencing of human cells. These unbiased, complementary
distributions of adducts and mutations will be compared to the location of genomic features such as transcripts
and R-loops to assess their influence on the occurrence and spectrum of DNA-TOP1 adduct-induced
mutations. The distributions of these adducts and mutations will be further compared to the distribution DNA-
TOP1 adduct signature mutations in sequenced human tumors to estimate the contribution of DNA-TOP1
adducts to mutagenesis in cancer. Completion of these aims will provide insight into the roles DNA-
topoisomerase adducts in cancer etiology, determine the primary mechanism(s) that generate transcription-
associated mutations, and create experimental systems that will facilitate future studies on the effects that DNA
structures, genetic determinates, and environmental exposures have on this understudied mutagenic pathway.

Public health relevance
Project Narrative Mutations initiate cancer development, contribute to metastasis, and cause therapeutic resistance. This proposal aims to demonstrate that DNA-topoisomerase adducts generated by transcription are responsible for many specific insertion and deletion mutations in human tumors and to uncover the mechanism(s) that convert DNA-topoisomerase adducts into mutations. Completion of this proposal will generate opportunities for additional studies investigating DNA-topoisomerase adducts, will create of systems that will facilitate future studies of mutagenesis in human cells, and highlight transcription as a critical mutagenic process in human tumors.